GENETIC AND MOLECULAR CHARACTERIZATION OF NUCLEAR MITOCHONDRIAL DNA IN FELIDS

Complete sequences of authentic feline mitochondrial (mt) DNA (approximately 17 kilobases [kb]) and mtDNA fragments transposed into a specific chromosome site (7.9 kb) were determined as an approach to elucidating the molecular aspects of gene transposition, gene amplification, and mtDNA evolution. Comparison of the two types of mtDNA sequences has provided useful information on the types and extent of mutations and the rate of mutation. These analyses revealed a relatively low amount of sequence divergence (5.1%) between these two types of mtDNAs, indicating recent integration and amplification of mtDNA in a chromosomal DNA within the last 3 million years. Dinucleotide repeats, d(CA)n, which are located in the breakpoint of the nuclear mtDNA, may suggest the involvement of these repeats in recombination and integration of nuclear mtDNA. Molecular cloning of flanking sequences of the nuclear mtDNA are underway to reveal the mechanism(s) for the amplification and integration of these mtDNA fragments.